Accelerating the Discovery of Antifungal Peptides with OBOC Combinatorial Technology.

Project Summary
Invasive fungal mycoses are a major threat to global human health. Despite the morbidity and mortality caused
by fungal infections, and the looming threat of multi-resistance, there has been no substantial advancement in
the development of antifungal agents. Although antifungal peptides (AFPs) are gaining popularity as potentially
new antifungal agents, the lack of innovation in the AFP space has stifled development. To tackle these major
challenges, we capitalized on the one-bead one-compound (OBOC) combinatorial technology and devised a
high-throughput, multi-step, fluorescence-based platform for screening chemically synthesized peptide libraries
to identify membrane-active antifungal peptides on the basis of their ability to discriminate between fungal and
mammalian plasma membrane compositions of giant unilamellar vesicles (GUV). The proposed research will
test the hypothesis that the enabling OBOC technology, in combination with two powerful screening strategies
(GUV binding assay and cell-based anti-fungal lawn assay), will enable us to rapidly develop and optimize novel
antifungal agents possessing defined physiochemical features required for broad-spectrum antifungal activity,
diverse mechanisms of action and a high therapeutic index. The scientific premise supporting this hypothesis
includes our published data and preliminary evidence demonstrating: (1) a new peptide K-oLBF127 that shows
high selectivity and potency towards fungal cells thus validating our OBOC GUV binding assay; (2) the feasibility
of our high-throughput cell-based antifungal lawn assay with OBOC cleavable peptides and (3) the promising in
vivo antifungal activity of our lead peptide, K-oLBF127. Our goals are to scale up our OBOC GUV binding assay
and expand our screen to include more complex peptide structures, and to use homolog OBOC releasable
peptide libraries with a cell-based antifungal lawn assay to further optimize these membrane active AFPs. In
addition, we will use the antifungal lawn assay to screen OBOC libraries for new antifungal agents. The most
promising AFPs will be fully characterized for their efficacy, safety and antifungal activity in vitro as well as in
murine models. Our studies will focus on Aspergillus fumigatus, Candida albicans, Candida auris and
Cryptococcus neoformans – all designated as fungal threats of the highest priority by the World Health
Organization. The highly complementary expertise of the PIs will generate meaningful interactions and foster
data sharing for greater impact.

Public health relevance
Project Narrative The proposed research is relevant to the part of NIH’s mission that pertains to improving human health by the discovery and development of novel antifungal peptides for the treatment of invasive, life-threatening fungal infections. The proposed studies address the “call to action” issued by the World Health Organization (WHO) recognizing that invasive, deadly fungal diseases are a significant threat to global human health.